Inhibitory Processing and Social Learning in the Mouse Accessory Olfactory Bulb

Project Summary/Abstract
Chemosensory systems contribute extensively to social behavior in humans and other mammals,
including mice, a predominant animal model for diseases and disorders that impact human social
function. We propose to study the neural circuitry of the accessory olfactory system in order to better
understand how this system extracts information from chemical messages and informs social
behavior. Without improved understanding of these processes, we risk making mistakes in the
interpretation of studies seeking new therapies for diseases and disorders involving social behavior.
The activity of excitatory projection neurons called mitral cells (MCs) in the first neural circuit in the
accessory olfactory system, called the accessory olfactory bulb (AOB), strongly influences
reproductive physiology and social behavior. AOB mitral cell activity is tightly controlled by several
types of GABAergic interneurons: juxtaglomerular cells, external granule cells, and internal granule
cells (IGCs). We and others have identified that AOB IGCs undergo experience-dependent plasticity
following chemosensory social behaviors. We will investigate the hypothesis that these cells, and
perhaps other AOB interneurons, are involved in social behavior plasticity.
We will use a combination of physiological techniques to investigate cellular and synaptic
physiology in AOB interneurons that undergo experience-dependent plasticity. We will study the
impacts of interneuron plasticity on chemosensory tuning. We will use targeted viral transgenic
strategies to selectively suppress activity of plastic AOB interneurons in vivo and ex vivo while
measuring population AOB MC activity using 2-photon calcium imaging and electrophysiological
recordings. These experiments will provide mechanistic tests of the hypothesis that experience-
dependent plasticity in AOB interneurons suppresses activation by learned, but not unlearned,
chemosignals. Finally, we will investigate the impacts of plastic AOB interneurons in social behavior
plasticity and brain-wide patterns of neuronal activation during repeated social encounters.
Combined, these studies will fill major gaps in our understanding of chemosensory information
processing, experience-dependent plasticity, and mammalian social behavior.

Public health relevance
Project Narrative The proposed research will investigate the role of inhibitory plasticity in the accessory olfactory system, a neural pathway that strongly influences social behaviors in mice. Mice are the predominant mammalian model organism, and evaluating mouse social behaviors is a core component of research into several neuropsychiatric disorders, including autism and schizophrenia. This proposal will improve our understanding of the role of inhibitory plasticity in chemosensory information processing and the development and maintenance of mammalian social behavior.